A Receptor-Targeted Nanoparticle PET Tracer in Human Carotid Atherosclerosis

PROJECT SUMMARY
Currently no consensus exists in clinical guidelines for management of patients with asymptomatic carotid artery
stenosis (ACAS). Some guidelines recommend carotid endarterectomy (CEA) surgery for patients with ACAS of
≥ 60% diameter. However, it is argued that 95% of all surgical interventions for ACAS in the United States may
be unnecessary, generating needless healthcare costs of >$2 billion annually. Our goal in this proposal is to
study plaque biology in ACAS patients through PET imaging at the molecular level to help identify individuals
who are at 'higher-risk’ for ischemic stroke from plaque rupture and may benefit from carotid surgical intervention.
We propose a 2-center patient outcomes study that expands upon data and observations from our earlier single
center first-in-human study at Washington University using a nanoparticle PET radiotracer that targets the
natriuretic peptide receptor C (NPRC) to determine if it can be used to risk stratify patients with ‘higher-risk’
ACAS. We and others have shown that NPRC is expressed at higher levels in complex plaques with features
of vulnerability in patients with ACAS. In our most recent NIH R01-funded proof-of-concept study in a cohort of
42 patients with ACAS, we have shown linear correlation between 64Cu-CANF-Comb PET radiotracer uptake
and features of high-risk plaque and correlative 64Cu-CANF-Comb PET uptake to the presence of NPRC in CEA
specimens of patients who underwent surgery. We propose the following Specific Aims: Aim 1. To determine
the ability of 64Cu-CANF-Comb PET to risk stratify ACAS patients treated with optimal medical therapy
(OMT) alone with respect to patient outcomes. In this observational study, 80 patients with ACAS ≥ 60% will
undergo 64Cu-CANF-Comb PET/MRI. Patients will be maintained on either OMT alone or receive OMT and CEA
as determined by their treating vascular surgeon prior to imaging. OMT will consist of antiplatelet, statin, and
hypertension and diabetes management when applicable. All patients will be evaluated with phone interviews
every 3 months for a minimum of 18 months to assess for ipsilateral ischemic cerebrovascular event. PET signal
will be assessed as a marker of risk for event or progression to CEA in comparison to anatomic features of
vulnerable plaque on MRI, with the goal of determining a PET signal threshold which suggests higher risk ACAS.
Aim 2: To further understand the role of NPRC in the evolution of carotid atherosclerosis. A. Patients
treated with OMT alone will undergo repeat PET/MRI at 18 months, or earlier if they develop symptoms. PET/MRI
changes over the 18-month interval will be used to further understand the biology of carotid plaque evolution
after treatment with OMT. B. In patients who initially undergo CEA, PET signal will be compared to ex vivo plaque
vulnerability and NPRC cellular distribution to facilitate understanding of gene expression using
immunohistochemistry (IHC) and cell origin through single cell RNA/CITE-seq transcriptomics. Results will
provide information on the potential of a new imaging approach, 64Cu-CANF-Comb PET, to risk stratify patients
with ACAS and reveal mechanistic information about the role of NPRC in plaque vulnerability and inflammation.

Public health relevance
PROJECT NARRATIVE Our research has shown that uptake of our new PET radiotracer, 64Cu-CANF-Comb, in carotid atherosclerotic lesions in patients with asymptomatic carotid artery stenosis who underwent carotid endarterectomy (CEA) surgery correlates with features of high-risk plaque in ex vivo CEA specimens collected from these patients. Additionally, preliminary retrospective assessment of outcomes in asymptomatic carotid artery stenosis patients who did not go on to surgery showed higher PET uptake of radiotracer in patients who later had ischemic cerebrovascular events than in patients who did not. In this proposal, we further explore the potential of this PET radiotracer to stratify asymptomatic carotid artery stenosis patients, identifying patients with ‘higher-risk’ atherosclerosis who would most benefit from surgery.